Engineering the Vocal Fold Mucosa

Project Summary/Abstract
Vocal fold (VF) mucosa is critical to vocal quality; poor healing ability and limitations of surgical repair have
motivated strategies to engineer living tissue replacements. A lack of fundamental understanding of the
complexity of VF mucosa's cellular and spatial heterogeneity is largely responsible for incremental progress
being made in VF tissue engineering. The overall objective of this proposal, which is a necessary step towards
achieving our long term goal of engineering replacements for VF mucosa, is to link single-cell RNA sequencing
and spatial transcriptomics, at exceptional resolution, to characterize VF morphogenesis across time, location
and cellular compartments and in response to injury. We will create large-scale single cell spatiotemporal
atlases of VF mucosa. In specific aim 1 we will identify and characterize murine VF cell populations and their
spatial distribution through embryonic and postnatal development. In specific aim 2 we will identify and
characterize human VF cell populations and spatial distribution across the lifespan. Results will provide
markers for characterization of proper tissue assembly and maintenance, which can then be applied as design
parameters for tissue engineering approaches. Cross-species validation will be a powerful strategy for
optimization, to prioritize genes and pathways for further investigation. Work in specific aim 3 will molecularly
profile cell subsets involved in VF injury and repair in a murine mucosa injury model. We will identify
subpopulations of fibroblasts and epithelial cells that respond to injury. Characterizing the relationship
between specific cell subpopulations, their interactions, spatial location and pathways involved in VF injury and
repair, will identify therapeutic avenues to mitigate VF scarring. The innovative use of transcriptional profiling
as an anchor of our research strategy, will provide differentiation criteria and vital tissue engineering design
parameters that can be used for the regeneration of new, normal VF mucosa.

Public health relevance
NARRATIVE STATEMENT: Voice disorders affect an estimated 3-9% of Americans yearly and 29% of the population in their lifetime. Treatment for vocal fold scarring, a voice disorder caused by tissue injury or loss has been limited. In this application, we seek to link single-cell RNA sequencing and spatial transcriptomics, at exceptional resolution, to characterize VF morphogenesis across time, location and cellular compartments and in response to injury. Whereby, providing a novel and fundamental approach for improving our understanding of VF health and disease, and will allow for optimization of engineering processes.